ICSC Applied Research Project

PROJECT SUMMARY – RESEARCH
The NIH MMRRC archives, curates, and distributes mouse models of scientific interest to the research
community at minimal cost. While this organization should accelerate the pace of research and provide greater
rigor and reproducibility, there have been no studies that show how successful the program is. The objective of
the proposed Applied Research Project is to better understand the specific impact of the MMRRC on research.
Aim #1 proposes to produce high resolution measurements of how the MMRRC products are used across the
research spectrum as well as details about the users. These studies will indicate the breadth and depth of
research supported by the MMRRC. Aim #2 proposes to measure the impact of the MMRRC by asking questions
such as “are MMRRC users more effective scientists?” This kind of question can be answered by comparing
MMRRC products and users to non-MMRRC products and non-users. Aim #3 proposes to develop research
fingerprints which assist in uniquely identifying research products and authors in the absence of the unique
identifiers provided by RRIDs and ORCID iDs. This will allow us to study the history of MMRRC impact. Research
fingerprints are also useful in clustering researchers by their interests, which will allow us to proactively suggest
mouse models to scientists with shared research interests.